Immunity and Infectious Disease

Project Summary/Abstract:
This application is a resubmission of a renewal for a pre-doctoral training program in Immunity
and Infectious Disease at The Rockefeller University, an institution with a rich history in these
areas. The Immunity and Infectious Disease Training Program is specifically designed for
education in immunology and infectious disease, and incorporates required coursework,
professional skills development, rotations, and extensive research opportunities. Trainees will
complete thesis work comprising a body of novel scientific work in immunology and infectious
disease. The 21 faculty trainers are accomplished scientists, including 8 members of the US
National Academy of Sciences and one Nobel laureate, with a shared interest and experience in
graduate education. The faculty has expertise in a very broad range of immunology and
infectious disease, and the program encourages trainees to perform collaborative work in
various areas with different faculty.
We propose to support 6 pre-doctoral trainees during years 2-4 of graduate study. The applicant
pool is outstanding, including a large number of students with accomplished undergraduate
records, extensive research experience and a strong interest in immunology and infectious
disease. Trainees would be mentored by the Program Director; members of the university
Dean’s Office, a Program Advisory Committee of selected faculty for general curriculum and
research advice; and a Faculty Advisory Committee, specifically designed for each trainee to
provide detailed experimental guidance. An External Advisory Committee will evaluate the
effectiveness of the program and provide advice on new initiatives.
Finally, the University provides extensive support for the graduate program in general, which
benefits the Immunity and Infectious Disease training program. The confluence of these
attributes defines a specific training program that will prepare trainees with the educational
background, analytical abilities, and experimental expertise for exciting career pathways in
immunology and infectious disease.

Public health relevance
Project Narrative: This training grant supports research and education that is directly relevant to public health, including clinically relevant coursework and research opportunities in areas including tumor immunology, inflammatory bowel diseases, HIV, Hepatitis C, tuberculosis, and SARS-CoV-2.